Cochlear resident tissue macrophages in normal cochlear development and the response to CMV infection

PROJECT SUMMARY / ABSTRACT
Congenital cytomegalovirus (CMV) infection can lead to sensorineural hearing loss (SNHL) long after resolution
of acute infection, implicating lasting alterations to tissue immunity, but the underlying pathogenic mechanisms
remain poorly understood. The long-term goal of this project is to define the mechanisms by which congenital
infection impinges on cochlear immune development to drive SNHL. The overall objectives in this application
are (1) to determine the contribution of the fetal host immune cells, specifically resident tissue macrophages
(RTMs) to normal cochlear development and (2) to determine how CMV shapes tissue immunity during perinatal
development to drive cochlear dysfunction. The central hypothesis is that RTMs are crucial to normal cochlear
development and that the response of fetal-derived RTMs to CMV infection is a critical mediator of cochlear
damage that drives SNHL. Our preliminary data indicate that fetal macrophages of distinct ontogenetic origin
seed the cochlea in a specific spatiotemporal pattern. Temporal blockade of CSF1R, a regulator of fetal
macrophage development, causes cochlear impairment and SNHL. Together, these findings suggest that fetal-
derived RTMs are critical regulators of normal cochlear development and tissue homeostasis, but the precise
mechanisms have not been delineated. The central hypothesis will be tested by pursuing three specific aims: 1)
Define the contribution of fetal RTMs to normal cochlear development; 2) Determine the effect of acute CMV
infection on RTM development; and 3) Determine the immune drivers of progressive SNHL following acute CMV
infection. In the first aim, we will employ fate-mapping and deletion of specific ontogenetic macrophage subsets
to define the spatiotemporal seeding and function of distinct waves of RTMs in normal cochlear development. In
Aim 2, we will investigate the effect of acute CMV infection in the perinatal period on seeding, transcriptional,
and functional regulation of RTM development in the cochlea. In Aim 3, we will examine how replacement of
fetal RTMs with adult BM-derived RTMs reshapes cochlear immunity and cochlear function, both under
homeostasis and in response to acute infection. We will combine fate-mapping, transcriptomic analysis and
genetic deletion models to define how replacement of fetal RTMs with BM-derived RTMs contributes to cochlear
inflammation, immune cell infiltration, and hearing function. The research proposed in this application is
innovative because it examines the origins of CMV-associated SNHL and cochlear dysfunction from the
perspective of immune ontogeny and because it integrates state-of-the-art fate-mapping and deletion models
with single-cell transcriptomics, advanced microscopy, and specialized hearing tests to perform highly detailed
mechanistic studies over the course of CMV pathogenesis and associated SNHL. The proposed research is
significant because it will contribute fundamental knowledge about the developing auditory system and provide
strong scientific justification to examine RTMs as a potential novel therapeutic target for SNHL treatment.

Public health relevance
PROJECT NARRATIVE / RELEVANCE TO PUBLIC HEALTH The proposed research is relevant to public health because it focuses on developing novel alternative strategies to treat Cytomegalovirus (CMV) mediated hearing loss by investigating the role of fetal-derived resident tissue macrophages in normal cochlear development and during this intrauterine infection. Once such strategies have been developed, there is the potential for a significant advance in treating patients with CMV and possibly other types of hearing loss. Thus, the proposed research is relevant to NIDCD’s mission to conduct and support research in the normal and disordered processing of hearing, balance, taste, smell, voice, speech and language.